MFRPS Conformance Grant

Project Abstract Significant compliance with the Manufactured Foods Regulatory Program Standards will ensure that the Mississippi State Department of Health is contributing to continuity of national food safety initiatives and thus protecting the consuming public from foodborne illness.

Public health relevance
Project Narrative Achieving conformance with the Manufactured Food Regulatory Program Standards by developing and maintaining best practices for a high quality regulatory program for the Mississippi State Department of Health (MSDH) Division of Food Protection will enhance the State and Federal food safety agencies’ ability to reduce foodborne illness hazards in food/feed plants.